Clinical Intervention and Translation Core

PROJECT SUMMARY/ABSTRACT – CLINICAL INTERVENTION AND TRANSLATIONAL CORE
Clinical-Translational research is such a priority for the Colorado NORC that we have a scientific core
laboratory devoted to fostering clinical and translational research. The Clinical Intervention and Translation
(CIT) Core of the Colorado NORC began operation in August of 2010, year 16 of this grant. It was created
because of a growing need by many NORC users for help with a wide range of clinical research studies
involving modification of body weight, diet, and exercise to evaluate impact on a range of physiological and
behavioral outcomes. During the first 14 years of funding for the Colorado NORC, we experienced substantial
growth in the number of investigators in the user base interested in weight management and in assessing the
impact of diet and exercise interventions on health. This gave us the opportunity to create a center of
excellence in weight loss maintenance and behavioral interventions, that we believed could make substantial
contributions to the scientific underpinnings to the national agenda to address the problem of obesity. The CIT
Core takes advantage of the Anschutz Health and Wellness Center (AHWC), a 95,000 sq ft state-of-art center
for supporting lifestyle intervention studies, including in areas of nutrition, physical activity and mental
wellbeing.
The CIT Core offers consultations for NORC researchers interested in designing and implementing clinical or
translational research involving nutrition, physical activity, weight management and wellness. This includes
consultation on research design, target populations, outcome assessment, and study implementation. The CIT
Core has expertise in conducting research in traditional clinical settings and in schools, worksites and
communities. In addition, the CIT Core offers a number of different programs for producing and maintaining
weight loss including the Colorado Weigh, My New Weigh, The State of Slim, and others. NORC investigators
can use these programs in their research studies. Costs of the programs will be negotiated with individual
researchers and costs depend on the level of involvement of CIT Core staff. The CIT Core has worked to
support the development and implementation of exercise interventions for research projects as well. The
30,000 sq ft fitness facility at the AHWC has state of the art cardio and resistance training exercise equipment
(Technogym, Cesena Italy) that utilizes an “app” based system that provides sophisticated `supervision' and
monitoring of compliance with a prescribed exercise intervention. This technology allows accurate reporting of
the actual bouts of exercise performed by individual subjects participating in an exercise training program.
Over the next 5 years of funding, the CIT Core will increase its activities in support of nutrition needs in
collaboration with the CCTSI Nutrition Core as well as in areas of behavioral health and electronic information
systems to collect and access data.